Mental Function And Quality Of Life With Chronic Pain

Background: Chronic pain is common in Veterans and astute rehabilitation plans are critical to avoid deleterious
outcomes for functional outcomes and other quality of life (QoL). Attaining optimal functional outcomes after pain
rehabilitation is challenging, however, in cases when a significant portion of disability stems from “nonorganic”
psychological factors. Disability from primarily psychologically-driven factors would make a Veteran a poor
candidate for invasive medical procedures (which would have minimal benefit and potential harms). Nonorganic
pain has been traditionally probed using clinician-rated “Waddell signs.” However, these signs are inconsistently
probed, with questionable inter-rater reliability and can be challenging in the VHA wherein symptom endorsement
can be financially reinforced. Therefore, there is a critical need for a time-sensitive, hard-to-feign objective marker
of psychologically-driven disability for treatment planning. This project is a proof-of-concept study to determine
whether subconscious bias toward pain, such as attentional capture by pain-related stimuli, correlates with mood
symptomatology and clinician impressions of psychologically-driven disability at intake, with an exploratory aim
of relating bias metrics to pain treatment outcomes. Approach: Over a 15-month period, 50 Veterans slated for
assessment at a VA medical center (VAMC) pain clinic and 30 “control” Veterans slated for a non-pain-related
appointment (e.g. Primary Care) with minimal pain histories will identified from electronic medical records (EMR)
and approached prior to their intake appointment and invited to complete a ~90-minute assessment battery on
a portable touchscreen-tablet-PC, either in their home or at the VAMC. This battery will be composed of
interview-based instruments of pain symptomatology and disability (e.g. occupational function), affective
symptomatology and QoL, as well as performance of neurocognitive tasks of subconscious bias toward pain-
related concepts/words and pain-related images. Comparator tasks of impulsivity and frustration tolerance will
also be included. This assessment will conclude with the patient making ratings of the burden or aversiveness
of the assessments themselves. Six months following this assessment, participants will repeat by telephone
interview the pain symptom, pain disability and QoL assessment items probed at baseline. In addition to the core
goal of probing the feasibility of computerized bias assessment in Veterans with chronic pain, analyses will test
for: 1) differences in subconscious pain bias between pain and non-pain patients, and 2) correlations between
subconscious bias and mood/pain/disability/QoL symptom scores at baseline, to assess the core validity of
probing subconscious bias measures in pain patients. As value-added supplemental analyses, we will: 1) relate
assessment items (both bias tasks and interview instrument scores) to Waddell ratings of intake clinicians noted
in EMR, 2) relate attentional (implicit) bias scores to pain and disability ratings at follow-up. Follow-on MERIT
projects: Many Veterans who show signs of psychologically-driven disability are reluctant to adopt provider
recommendations to seek integrative mental health care. To help providers motivate these patients, follow-on
MERIT studies will collect evidence that Veterans with psychologically-driven pain disability selectively benefit
from wrap-around mental health care. The strongest neurobehavioral markers (of self-reported and clinician-
rated psychological distress) from the laptop assessment of this I21 project will be ported to a mobile app testing
platform for a full-scale observational study designed to show whether app (task) results are predictive of pain
treatment outcomes, as a function of whether mental health services were utilized. These data will enable the
testing app to return actual bias “risk” scores to the patient and provider. In a subsequent clinical trial of the app’s
risk score, we will compare functional rehabilitation outcomes when the psychological risk rating is (one study
arm) vs is not (other arm) available to the provider for treatment planning. Rehabilitation outcomes in terms of
whole QoL and pain symptomatology will be tracked and compared between groups as a function of (interaction
with) whether app-flagged (probable-nonorganic pain) cases were given integrative mental health services.

Public health relevance
Many Veterans suffer chronic pain from deployment-related injuries or other causes, resulting in poor quality of life. The amount of disability a Veteran suffers is a combination of injury (biological or neurological processes) and mental interpretation of the pain signals. In many cases, no physical problem is detected in an X-ray or other scan. Patients whose pain disability is amplified by psychological factors can benefit from receiving cognitive behavioral therapy and other mental health (MH) care in addition to medical procedures. However, many refuse this MH care. To help motivate these Veterans, this study will explore whether subconscious bias toward pain revealed in special computer tasks may be a useful marker to identify Veterans who could benefit from MH care. The study will explore how feasible it is to test for this bias with computer tasks, and whether subconscious bias is greater in pain patients compared to other kinds of Veteran patients, and whether bias relates to other measures of psychological distress. These data will help develop a mobile app that could motivate MH care.